Sex Differences in Barriers and Predictors of Physical Activity Participation During and Following Cardiac Rehabilitation

PROJECT SUMMARY
This K01 Career Development Award will inform the design and development of an R01-level
intervention utilizing health coaching and precision-level strategies to cultivate PA maintenance as
women transition from CR into the real world. Cardiovascular disease is the leading cause of death for
women in the United States. Cardiac rehabilitation (CR) can play an important role in attenuating
cardiovascular disease progression, reducing morbidity and mortality, and improving quality of life.
Unfortunately, CR programs have limited success in producing sustained behavior change beyond the
structured program, especially among women, mitigating long-term health benefits. Given women
appear to participate in less PA during and following CR, there is a critical need to understand whether
they have different barriers and thus different predictors of PA participation and maintenance. Prior
research investigating barriers and predictors of PA participation during and after CR has been limited
by the study population, which has been predominately male. Thus, the proposed project will utilize an
observational study design to assess the following aims: 1) among individuals enrolled in CR, identify
sex differences in PA participation during CR and PA maintenance after CR completion; 2) identify sex
differences in patient-level barriers to PA participation during CR and PA maintenance after CR
completion; 3) identify key predictors of PA participation during CR and PA maintenance after CR; and
Sub-Aim 3a) determine whether identified predictors of PA participation and maintenance differ by sex.
My central hypothesis is that 1) sex differences in PA participation, barriers to, and predictors of PA
during and following CR will be identified; and 2) qualitative experiences of men and women will provide
a mechanism to tailor a PA transition program to better support women in improving cardiovascular
health and CR recurrence. The proposed research plan will advance the applicant’s career, Katherine
A. Collins, PhD facilitating her transition to independent investigator status over the five years of K01
support. A team of highly productive, multidisciplinary scientists (Drs. William Kraus, Jennifer Gierisch,
and Valerie Smith) will collectively serve as mentors to Dr. Collins during the proposed research at
Duke University. This team of mentors has the expertise to train Dr. Collins in 1) qualitative and mixed
methods research; 2) predictive analytics, longitudinal data analysis, and sex differences; and 3)
grantsmanship and professional development. The proposed training and expert mentoring team will
provide Dr. Collins with the skillset, preliminary data necessary to compete for R01 funding, and
protected time to establish an independent laboratory. In sum, this award will serve as a catalyst for
making Dr. Collins a leader in the field of precision lifestyle and exercise medicine.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of death for women in the United States; with cardiac rehabilitation (CR) playing an important role in attenuating cardiovascular disease progression, reducing morbidity and mortality, and improving quality of life. Unfortunately, CR programs have limited success in producing sustained behavior change, and most research investigating this has been limited to male-dominated populations. Thus, the proposed project aims to 1) identify sex differences in PA participation during and following CR completion; 2) identify sex differences in patient-level barriers to PA participation during and following CR completion; 3) identify key predictors of PA participation during and following CR; and Sub-Aim 3a) determine whether identified predictors of PA participation and maintenance differ by sex.